Virginia Division of Consolidated Laboratory Services Laboratory Flexible Funding Model

RFA-FD-25-007 Laboratory Flexible Funding Model (LFFM) (U19)
Virginia Division of Consolidated Laboratory Services
Project Summary
Principal Investigators: Jessica Price, Ph.D. and Amanda Woods
The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the
Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and
federal agencies, local governments and other states in support of public health, environmental
protection, food safety, and emergency response. DCLS provides surveillance and emergency
response testing of food samples for the Virginia Department of Agriculture and Consumer
Services (VDACS) Food Safety Program by offering comprehensive testing of food samples by
microbiology, chemistry, and radiochemistry methods. DCLS obtained ISO/IEC 17025
accreditation in January 2017 and has since expanded this scope of accreditation to include
seven chemical methods and five microbiological methods. DCLS proposes to maintain and
further expand this accreditation scope to include up to three new test methods during the
budget period. DCLS’ experience with testing MFRPS food samples for our state partners along
with participation in proficiency testing events, dedicated BSL-2 trained staff, dedicated
laboratory space and equipment along with our long-standing history with the FERN Network,
sets DCLS apart from other state testing facilities.
If granted these funds for all three disciplines, DCLS is committed to providing emergency
testing, surveillance and regulatory human and animal food testing for any situation when called
upon by the FDA. DCLS is also committed to providing testing support for national security
events as well as participate in all proficiency tests and training when applicable. DCLS will
participate in FDA-requested exercises and surveillance activities to support and maintain a
state of readiness. Additionally, DCLS will ensure analysts are trained and have current
documented competency, all equipment and instruments remain in working order, and reagents
and supplies are available or could quickly be procured in the event of an emergency.

Public health relevance
RFA-FD-25-007 Laboratory Flexible Funding Model (LFFM) (U19) Virginia Division of Consolidated Laboratory Services Project Narrative Principal Investigators: Jessica Price, Ph.D. and Amanda Woods This cooperative agreement is intended to enhance the capacity and capabilities of state human and animal food testing laboratories in support of an integrated food safety system (IFSS). This is achieved through prioritized sample testing and food defense preparedness in the areas of microbiology, chemistry, and radiochemistry, as well as method development and capacity/capability development projects that support and expand food safety and food defense testing.